Supplement to Accelerating photoreceptor replacement therapy with in-vivo cellular imaging of retinal function

To restore high quality, usable vision in patients, it is important to develop regenerative therapies in an animal
model that shares key features of the human visual system. The non-human primate has a virtually identical
retinal anatomy and physiology to the human and, uniquely amongst mammalian models, shares a fovea,
the retinal area specialized for high acuity vision. Whilst the non-human primate is the gold standard animal
model for research on human vision, its utility for pre-clinical testing has been limited due to both the absence
of models of vision loss and the difficulty of demonstrating restored function. Under previous AGI funding, the
Advanced Retinal Imaging Alliance at the University of Rochester has recently overcome these challenges
to create a pre-clinical testing platform leveraging adaptive optics technology to: 1.) Create localized regions
of photoreceptor ablation in primate that are axially confined, and 2.) Optically read out restored retinal
ganglion cell function by performing cellular scale calcium imaging in the living eye. This system was
developed to meet the needs of photoreceptor replacement therapy which requires photoreceptor loss with
preserved host retinal circuitry. Furthermore, a high-resolution in vivo imaging approach is well suited for pre-
clinical evaluation of regenerative therapies where the timescales of restored connectivity are unknown and
functional integration occurs on the cellular scale. In this proposal, we will use our platform to generate pre-
clinical data that will inform future clinical trials of photoreceptor replacement therapy in patients. Functional
integration of transplanted photoreceptors with the host retina requires both high density delivery of high-
quality donor photoreceptors and a host retina with the capacity for synaptogenesis. We have assembled a
consortium that can explore and optimize both sides of this interaction. In continued collaboration with a team
at the University of Wisconsin led by David Gamm, a clinician and expert in the development of human
pluripotent stem cell (hPSC) derived photoreceptor replacement therapy, we will evaluate survival and
functional integration of transplanted photoreceptor precursors in primate fovea delivered to the sub-retinal
space as aggregates or following incorporation into custom biodegradable scaffolds. In collaboration with a
team at University of California, Berkeley led by Teresa Puthussery, an expert in retinal remodelling in retinal
degeneration models and primate histology, we will examine the impact of the loss of photoreceptor signalling
on primate inner retina. We will explore whether deafferented cone bipolar cells can remodel and functionally
integrate with donor photoreceptors and whether retinal hyperactivity develops in primate as it does in rodent.
To make meaningful progress toward restoring vision in patients who have lived with vision loss for many
years, we will examine how these phenomena develop in the primate fovea over time and whether the
regenerative potential of the host can be improved by therapeutic interventions such as retinoic acid blockers.
These studies will allow us to fully characterize our primate photoreceptor ablation model and deploy it with
photoreceptor replacement therapies to advance the field toward clinical trials.

Public health relevance
Vision loss exacts an enormous toll on individuals and on society, and progress has been slow in developing therapies for restoring vision in the blind. To greatly reduce the time required to develop effective cures for blindness, we have a new way of imaging the retina that can provide information about whether retinal cells benefit from new therapeutic approaches. This novel functional imaging technique will be applied to evaluate photoreceptor replacement therapy in the fovea, the area of the retina that mediates high quality vision. Success in restoring vision at this location will provide strong evidence that this type of therapy could restore usable vision in patients and regenerative therapies should move rapidly into clinical trials.